Clinical Research Resources and Facilities Core

DACCOTA-Clinical Research Resources and Facilities Core
Summary: The overall goal of the Clinical Research Resources and Facilities Core is to provide
synergy and expansion opportunities to the existing clinical services and technology cores
available through partnering institutes, thereby fostering an ideal environment for the competitive
execution of clinical and translational cancer research. This core will facilitate access to essential
services necessary for establishing, executing, and communicating clinical and translational cancer
research to allow for the seamless progression from ideas to results. The goal of this core is to
promote CTR by expanding the biorepository of biological samples essential for advancing
genomic/personalized medicine and translational research. Researchers will use these biobank
samples to identify biomarkers for cancer progression and prognosis and/or determine medication
tolerance. The DACCOTA will utilize an established biorepository with state-of-the-art technology
to handle and inventory all samples, while also linking patient samples to the electronic medical
records. The goal of this core is to share resources, develop new protocols for treating patients,
and assist with various clinical trials as we move forward with our mission to increase clinical and
translational cancer research.

Public health relevance
DACCOTA-Clinical Research Resources and Facilities Core Narrative: Communities in the Dakota region are disproportionately affected by multiple types of cancer and represent a significant underserved population for cancer treatment and care delivery. To address these issues, the Dakota Cancer Collaborative on Translational Activity (DACCOTA) will bring together clinicians and non-clinicians from across North and South Dakota, who will work collaboratively to promote and increase clinical and translational cancer research. Currently, many basic researchers and clinicians within the region lack access to the biospecimens, data sets, and clinical research infrastructure necessary to conduct clinical and translational research (CTR). Therefore, the Clinical Research Resources and Facilities Core (CRRFC) will expand and facilitate access to the Sanford Biobank and the large administrative patient data sets offered by the Sanford System and VA. We will also provide clinical research resources and share the clinical trial expertise of the Sanford Research group. The mission of the CRRFC is to foster an ideal environment for the competitive execution of clinical and translational cancer research.